NHGRI/DIR Microarray and single-cell Core

Microarrays and Single-Cell Genomics Core:
The NHGRI Microarrays and Single-Cell Genomics Core Facility represents a consortium between NHGRI, NIMH, and NINDS. It provides intramural investigators with full service, cost-effective and time-efficient access to state-of-the-art genomics and transcriptomics technologies for understanding genome copy number and patterns of gene expression. Most investigator project requests are Full Service, in which the investigator will provide the chips, labeling kit and isolated RNA samples, and the core will perform labeling, hybridization and data extraction. Upon project completion, the investigator is provided with a summary report including the data quality assessment, preliminary analysis and raw data output files. The core also provides hands-on training to investigators, upon request, for any of the platforms and specialized RNA protocol extraction, data quality control, data analysis, data mining and data troubleshooting. For single-cell sequencing and RNA-sequencing, users will be responsible for providing the sequencing kit and the core will provide the reagents for making the DNA libraries. For single-cell RNA-Seq, the users will be responsible for providing some reagents for droplet generation and the sequencing kit. After the RNA or cell suspension passes QC, DNA libraries will be generated and then subject to another QC before sequencing. The core will provide the sequencing QC and the FASTQ raw sequencing files. The PI will be provided with a BaseSpace link to view and download all raw and analysis files. For single-cell, the requester will be provided with the data QC and preliminary analysis and a tutorial on Partek-Flow software use.